MASLD protection by STAT5-regulated transcription factors

Summary/Abstract
Metabolic dysfunction-associated steatotic liver disease (MASLD) predisposes the liver to cirrhosis and
hepatocellular carcinoma and is a leading cause for chronic liver disease and liver transplantation. Importantly,
pre- but not post-menopausal women show a lower prevalence of MASLD than men. Clinical and experimental
studies indicate that growth hormone (GH) protects the liver from steatosis and MASLD progression, but the
underlying molecular and regulatory mechanisms are largely unknown. Prior work by our research groups
using a mouse model of adult-onset, hepatocyte-specific GH receptor knockdown indicates the protection
afforded females against MASLD can in part be explained by the sexually-dimorphic temporal pattern of
pituitary GH secretion, and consequently, sex-dependent GH-activation of hepatic Stat5 activity (persistent in
females vs. pulsatile in males); this, in turn, regulates the sex-dependent liver transcriptome, including
expression of key sex-dependent liver transcription factors (TFs). The work proposed builds on these prior
research findings and supports two central hypotheses: 1) integrative crosstalk between sex-biased TFs
controls the female-dependent actions of GH and Stat5 on the hepatocyte transcriptome to confer protection
from steatosis; and 2) persistent Stat5 signaling, as occurs in female liver, maintains hepatocyte-specific
programs that go beyond controlling steatosis, and interact with liver non-parenchymal cells to reduce fibrosis
and slow MASLD disease progression. To address these hypotheses, Aim 1 will use adult-onset, hepatocyte-
specific knockdown technology to elucidate contributions of two female-biased hepatocyte TFs to GH/Stat5-
signaling in sustaining female-biased gene expression and protection from steatosis. Aim 1 will also determine
the potential for one of these TFs, Cux2, to feminize the male liver transcriptome and prevent steatosis. In Aim
2, mice will be fed a translationally relevant diet that induces MASLD to elucidate the hepatoprotective actions
of persistent hepatocyte Stat5 activity on liver-specific disease progression. Single nucleus RNA-seq will be
used to elucidate how sex-dependent, hepatocyte-specific signaling downstream of Stat5 alters expression of
genes critical for controlling hepatocyte regeneration, senescence, stress and death, and their impact on cell-
cell communication with liver non-parenchymal cells key to MASLD pathology. Together, this work is expected
to shift current research paradigms on the hormonal control of sex-differences in liver disease, which are
largely focused on gonadal steroids, to elucidate how persistent, plasma GH pattern-determined hepatic Stat5
activity and its downstream sex-dependent liver TFs protect females across the spectrum of MASLD to slow
disease progression. Fundamental new knowledge will be gained in the fields of GH signaling and action, sex
differences in liver biology, and MASLD development, and is expected to have real potential to unveil novel
therapeutic strategies and druggable targets to treat this devastating disease and leading cause of liver failure.

Public health relevance
Narrative: Metabolic dysfunction-associated steatotic liver disease (MASLD) is more prevalent in men, compared to pre- menopausal women. Preclinical studies are proposed to elucidate underlying molecular mechanisms for how growth hormone (GH) protects hepatocytes within the female liver from excess fat accumulation and damage, and for how GH alters hepatocyte communication with other liver cell types to slow disease progression. The fundamental new knowledge gained in the fields of GH action, sex differences in liver biology, and MASLD development have real potential to unveil novel therapeutic strategies and druggable targets to treat this devastating disease, that has become the leading cause of chronic liver failure.